Emulating Immune Dysregulation by Trisomy 21 in a Multi-Organ-on-a-Chip System

Trisomy 21 (T21) is the molecular cause of Oown syndrome (OS), the most common chromosomal
abnormality in humans worldwide. Lung disorders represent an important cause of morbidity and
mortality in people with OS. Recurrent respiratory infections are particularly common in these
individuals and are often life-threatening. However, despite recent studies reporting immune
dysregulation and interferon hyperactivity in individuals with OS, there is a critical gap in our
understanding on how extra genetic material from chromosome 21 influences homeostatic immune
activity of the lung, and innate immune activation and mobilization of myeloid leukocytes, which
are key mediators of acute immune response, to respiratory pathogens. Organs-on-chips are
biomimetic, microfluidic, cell culture devices created with microchip manufacturing methods that
contain continuously perfused hollow microchannels inhabited by living tissue cells arranged to
simulate organ-level physiology. By recapitulating the multicellular architectures, tissue-tissue
interfaces, chemical gradients, mechanical cues, and vascular perfusion of the body, these devices
produce levels of tissue and organ functionality not possible with conventional two- dimensional or
three-dimensional culture systems. They also enable high-resolution, real-time imaging and in vitro
analysis of biochemical, genetic and metabolic activities of living cells in a functional tissue
and organ context. The overarching goal of this project is to apply microengineering principles of
organ-on-chip technology and develop a highly innovative and advanced, physiologically relevant
model of organ-organ crosstalk to delineate impact of OS on homeostatic physiology of the lung and
emulate clinically observed immune dysregulation due to T21. For this, we will create a
microfluidically integrated murine multi-organ system that reproduces bone marrow (BM)-lung axis,
using primary cells isolated from wild-type (WT) and Op(16)1/Yey mice (a murine model of OS). In
parallel, to enable eventual translation of findings to humans, we will focus part of our efforts
in generating human lung airway epithelia, vascular endothelium and hematopoietic stem cells from
induced pluripotent stem cells of healthy subjects and individuals with OS to recreate Lung and BM
tissue in the integrated multi-organ chip system. We will utilize these murine and stem cell-based
platforms to study how T21 affects normal functioning and biological responses of the lung airway
epithelium and endothelium. Moreover, we will in real-time analyze inflammation development and
innate immune cells mobilization in response to challenge with inhaled airborne influenza virus
particles. Our central hypothesis is that this dynamic living microsystem can recapitulate innate
immune dysregulation in OS, reveal a pulmonary exaggerated immune response to challenge with
inhaled infective agents, and enable discovery of previously unknown pathologies in airway function
in the context of a multi-organ physiologically linked system.

Public health relevance
Recurrent respiratory infections are particularly common in individuals with Down syndrome and are often life-threatening. Thus, it is important to understand the mechanisms by which the additional genetic material in Down syndrome impacts lung immune activity and response to respiratory pathogens; this would enable us develop/repurpose therapeutics that can protect people with Down syndrome against pulmonary infections. Here, we will apply organ-on-chip technology and develop a physiologically relevant murine and human stem cell-derived model of lung-bone marrow axis to delineate the impact of trisomy 21 on homeostatic physiology of lung, development of immune dysregulation, and presence (if any) and mechanisms of hyperreactivity to inhaled influenza virus infection.